Administrative Core

The administration of the Program is centralized in Core A and will be administered from University of Massachusetts - Amherst. This is a small but complex Program involving investigators from four distinct sites at University of Mississippi Medical Center, Univeristy of Florida and Mayo Clinic - Jacksonville. Thus it will require a great deal of coordination to ensure continuity and communication between the four groups of investigators. The function of the Administrative Core is to provide appropriate administrative service to the Program Director and the individual Project Leaders and Core Directors. These services are critical to the scientific function of the Program. The Administrative Core will ensure timely transfer of funds to each Project Director. This core also will ensure the NIH and NCI, NIA and NIAID program requirements will be met in a timely fashion. The core will set up meetings between Project/Core Leaders and ensure open communication between the institutions participating in the Program. This core also will organize travel related to the Program and facilitate submission of manuscripts. Lastly, the core will organize the yearly meeting with the external scientific advisory board. Because this is a multi-institution Program, an organized and involved Administrative Core is essential to complete the scientific goals of this Program.

Public health relevance
RELEVANCE (See Instructions): The function of the Administrative Core is to provide appropriate administrative service to the Program Director and the individual Project Leaders and Core Directors. These services are critical to the scientific function of the Program.